Streptococcal virulence regulation by a novel intercellular signaling pathway

Group B streptococcus (GBS) is a major human pathogen that causes significant morbidity and
mortality. GBS infections are the leading cause of stillbirths, preterm births, and neonatal mortality
worldwide. Owing to the lack of a human vaccine and rise in antibiotic resistance among GBS strains,
the clinical utility of current GBS infection control measures is significantly compromised. Thus, new
approaches and/or targets are urgently required to treat or prevent GBS infections. In the proposed
study, we seek to characterize a previously unknown intercellular signaling pathway and determine its
contribution to GBS pathogenesis. Recently, we discovered a broadly distributed, novel intercellular
signaling pathway in firmicutes that is comprised of a new class of bacterial intercellular signals,
leaderless communication peptides (LCPs), and a cognate intracellular receptor that controls virulence
gene expression in concert with LCP. Without exception, the cognate intracellular LCP receptors for all
the identified LCPs belong to a subfamily of the Rgg/Rap/NprR/PlcR/PrgX/AimR (RRNPPA)-super
family of peptide-sensing transcription regulators, the Rgg subfamily. As a result, the possibility that
LCPs act as signals for the members of other subfamilies of RRNPPA regulators is unexplored, and
the potential roles of an entirely new class of LCPs in bacterial group behaviors remain under
appreciated. Our preliminary data uncover a previously unknown AimR subfamily regulator and a
corresponding LCP in the GBS genome that likely controls the expression of genes encoding a putative
toxin and toxin-associated transporters. However, the critical knowledge regarding the components of
GBS LCP signaling pathway, molecular mechanism of GBS LCP signaling, and the contribution of LCP
signaling pathway and LCP-controlled putative toxin to GBS pathogenesis are yet to be elucidated.
Thus, the primary objective of the proposal is to dissect the signaling mechanism of AimR-LCP pair
of GBS, elucidate its regulatory activity in vivo, and determine its contribution to GBS pathogenesis.
We will test the central hypothesis of the proposal that AimRgbs-LCPgbs constitute a cytosolic
receptor-LCP pair that mediates intercellular signaling and controls virulence-associated traits of GBS
in two specific aims. The completion of this study will provide critical insights into the role of a novel
intercellular signaling pathway in the survival and virulence of a human pathogen and potentially identify
novel targets for future translational strategies to treat or prevent GBS infections.

Public health relevance
Group B streptococcus (GBS) is a major human pathogen and causes significant human morbidity and mortality worldwide. The proposed studies are relevant to the NIH mission as it involves the characterization of a novel virulence regulating intercellular signaling pathway, which may lead to the identification of novel therapeutic targets for GBS infection control.